TYPE 1 COPPER COORDINATION IN THE ABSENCE OF SULFUR

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. We have expressed and purified mutants of Pseudomonas aeruginosa azurins which possess reduction potentials and EPR spectra akin to type 1 (T1) or “blue copper” sites despite lack of thiolate ligation. To date research has indicated the necessity of thiolates for T1 coordination. In concert with ongoing electronic absorption, EPR, and electron transfer kinetics studies, we wish to use XAS and EXAFS analysis to elucidate the origin of our peculiar EPR spectra as well as to assess site reorganization during oxidation/reduction processes.